TREATMENT OF ENDOTOXIC SHOCK WITH AN ADENOSINE 3 AGONIST

The applicants are developing a novel principle (adenosine-3 agonism) with broad anti-inflammatory potential. In this proposal, we present evidence that an agonist of the adenosine 3 (A3) receptor (1) reduces the production of multiple pro-inflammatory cytokines and chemokines; (2) enhances the production of the anti-inflammatory cytokine IL-10; (3) inhibits the expression of the inducible isoform of nitric oxide synthase, an enzyme which is expressed in inflammation and produces cytotoxic amounts of the free radical nitric oxide and (4) protects in rodent models of shock and inflammation. The applicants propose to explore the efficacy of A3 agonists as anti- inflammatory drugs, and select a leading indication for further development. The specific aim of the present proposal is to perform in vivo studies in order to test whether A3 agonists can ameliorate the hemodynamic alterations and the development of multiple organ failure in endotoxic shock. Endotoxic shock, as a systemic inflammatory syndrome, represents a logical choice of an indication. The current study is mainly a feasibility study. Nevertheless, the results of the present application may be followed up with application for Phase 2 SBIR funding to support: additional shock studies in large animals, pre-clinical pharmaceutical testing (advanced toxicity determinations, pathology, stability, pharmacokinetics, in vivo efficacy), investigational drug application to the FDA and Phase 1 clinical trial. PROPOSED COMMERCIAL APPLICATIONS: Development of a potent adenosine-3 agonist for the treatment of endotoxic shock could result ultimately in commercialization of specific and effective agent for the clinical management of sepsis. Based upon current annual worldwide health care expenditure related to endotoxic shock ($10 billion), annual gross revenues are estimated to be in excess of $1 billion.